SPOP modifies neurodegenerative proteinopathy in Alzheimer’s Disease.

PROJECT SUMMARY
Aggregated pathological tau protein constitutes one of the diagnostic hallmarks of Alzheimer’s disease (AD) and
related disorders (ADRD). The molecular mechanisms by which pathological tau causes dysfunction and
degeneration of neurons remain incompletely understood. However, pathological tau driven neuronal dysfunction
and neurodegeneration clearly cause dementia. To investigate how pathological tau contributes to
neurodegeneration in AD and ADRDs, we established a transgenic model in Caenorhabditis elegans for
neurodegeneration driven by human tau aggregation. By employing classical forward genetic approaches, we
identified several genes whose loss of function suppresses tauopathy, including spop-1. SPOP (speckle-type
POZ protein) is a conserved nuclear adaptor protein for the RING E3 ubiquitin ligase Cullin-3 (CUL3), selecting
proteins for degradation in the ubiquitin proteasome system (UPS). After generating a true null allele via CRISPR-
cas9, we found that loss of spop-1 dramatically decreases tau accumulation and phosphorylation without altering
tau mRNA abundance, rescues lifespan, reduces neurodegeneration, and improves behavioral deficits in tau
transgenic animals.
In addition to its role in UPS activity, SPOP also undergoes liquid-liquid phase separation (LLPS) localizing to
nuclear speckles (NS). Our previously work in C. elegans and AD neurons indicate disruptions to NS function
and composition contribute to tau toxicity. Remarkably, loss of spop-1 also rescues C9orf72 dipeptide-repeat
toxicity in a C. elegans model of genetic amyotrophic lateral sclerosis (ALS) and frontotemporal lobar
degeneration (FTLD). Our preliminary results indicate loss of spop-1 suppresses behavioral deficits in C. elegans
expressing ALS-linked mutant TDP-43 as well as transgenics co-expressing TDP-43 and tau, which recalculate
AD and ADRD relevant interactions.
Altogether, our work led us to hypothesize that SPOP functions as a multipurpose regulator of proteinopathy in
AD and ADRDs. We hypothesize SPOP-CUL3 UPS activity and SPOP LLPS/NS localization contribute to the
underlying mechanisms of tauopathy. To investigate these hypothesizes the specific aims of this project are:
SPECIFIC AIMS: (1) Characterize SPOP loss of function in AD/ADRD neurodegenerative proteinopathies,
(2) Determine the mechanism by which SPOP loss of function suppresses tauopathy, and (3) Evaluate
the translational relevance of SPOP in Alzheimer’s disease.
By completing the proposed work, we will uncover new molecular understandings of disease mechanisms
including how SPOP protein – as well as nuclear speckles and Cullin-3 – participate in tauopathy and related
ADRD co-pathologies. This work will also provide insight into the translational relevance of SPOP in Alzheimer’s
disease brains, setting the stage for future study and informing the development of novel therapeutics.

Public health relevance
PROJECT NARRATIVE Pathological tau drives neurodegeneration in Alzheimer’s disease and Alzheimer’s Disease Related Dementia disorders, yet the underlying molecular mechanisms of tau toxicity remain incompletely understood. Our previous work in C. elegans shows SPOP controls pathological tau accumulation and suggests disruptions to nuclear speckles and the ubiquitin proteasome system as possible mechanisms for SPOP in disease. The completion of the proposed work will provide insight into the biological mechanisms driving tauopathy and establish the relevance of SPOP in Alzheimer’s disease.